The Role of Mitochondrial TNAP in Adaptive Thermogenesis

Abstract
Thermogenic adipocytes and adaptive thermogenesis are promising therapeutic targets for treating and
preventing obesity and obesity-linked diabetes. We recently demonstrated that the mitochondrial tissue-
nonspecific alkaline phosphatase, TNAP, plays a crucial role in the futile creatine cycle (FCC) and adaptive
thermogenesis by hydrolyzing phosphocreatine. Pharmacological inhibition or genetic ablation of TNAP in mice
reduces systemic energy expenditure. Genetic ablation of TNAP in mice also causes rapid-onset obesity. TNAP
assumes a mitochondrial localization specifically in thermogenic adipocytes, which might ensure the cell-
selectivity of the phosphocreatine hydrolysis events and the FCC operation. Here, we propose to study the
metabolic effects of gain-of- function of TNAP in the adipose tissues in mice, as well as the molecular mechanism
and regulation of its mitochondrial localization. Using a transgenic mouse strain that artificially expresses TNAP
in the adipose tissues, we will investigate its effects on obesity, diabetes, fatty liver, and energy expenditure. To
study the TNAP localization, we will test whether its cell specificity lies in the TNAP polypeptide or its trafficking
pathway, or both. I will first determine whether there are any molecular elements (e.g., PTMs or amino acid
sequences) on the TNAP polypeptide crucial for its mitochondrial localization. This will be done using a
combination of biochemical and cell imaging approaches. In addition, we will investigate the cellular pathway of
TNAP trafficking to mitochondria. We will interrogate the role of lipid rafts in TNAP localization. This might allow
us to identify key regulators and mediators of the mitochondrial localization of TNAP. Finally, we will identify
other mitochondrial proteins that share the localization pathway of TNAP and study their functions.
The candidate, Dr. Yizhi Sun, has a strong track record of innovative research with a focus on the molecular
mechanisms of diseases. The candidate’s career goal is to become an independent academic investigator with
a research laboratory oriented towards understanding and reversing obesity and obesity-linked metabolic
disorders. The proposed research will be conducted in the laboratory of Bruce Spiegelman, PhD at Dana-Farber
Cancer Institute and Harvard Medical School, who is a leader in the fields of molecular metabolism and adipocyte
biology. The proposed studies will also bring together leading laboratories of the advisory committee that have
expertise in cell imaging, protein trafficking, and mitochondrial biology. All of these, together with the ideal
research environment in the Longwood Medical Area, will maximize applicant’s potential to successfully
transition to an independent investigator.

Public health relevance
Project Narrative Obesity is an important public health problem and linked to metabolic disorders including diabetes, cardiovascular diseases, kidney diseases, and cancer. This research seeks to understand basic mechanisms of adaptive thermogenesis and to identify new ways to treat or prevent obesity.